Viral Vector

The Viral Vector Core (VVC) serves as a research facility that supports gene transfer studies. Its overall
objective is to support investigators in the use of gene transfer technologies, including consultation with
investigators, development of novel vectors, collaborative testing of vectors generated for function and
purity, and preparation including quality control. The facility serves both HCCC members and a significant
number of investigators from other NCI-designated cancer centers. VVC staff are active participants in the
development of gene transfer technologies in the cancer field. The interaction with multiple investigators
from various disciplines and institutions allows for cross-fertilization of ideas, technical advancements, and
innovations in vector designs. The VVC provides purified and concentrated preparations of recombinant
adenovirus, adeno-associated virus, vaccinia, baculovirus and retrovirus (including lentivirus). It also
provides access to standard cell lines, expression plasmids and a stock of recombinant reporter viral
vectors. The main responsibilities of the VVC are to: prepare recombinant vectors; perform relevant quality
control; disseminate vectors; maintain a database of vector stocks available for use; maintain a database
of expression vectors; develop new expression vectors as needed; develop novel methods for vector
production; and assist in the design and development of novel vectors.

Public health relevance
PROJECT NARRATIVE Not applicable